Interleukin-27 in host response to Legionella infection

Project Summary: Legionellosis (Legionnaires’ disease) is a form of atypical pneumonia with a steep rising
incidence in the United States. The mortality rates of patients stagnate around 3-30% despite treatment.
Legionellosis is caused by facultative, intracellular bacteria of the Legionellaceae family, which reside in natural
and engineered aquatic habitats. Inhalation of contaminated aerosols can lead to infection, evasion of pathogen
eradication and continuous replication in Legionella containing vacuoles inside alveolar macrophages (AMs).
The ensuing inflammation promotes an infiltration of myeloid cells and lymphocytes into lungs. These immune
cells communicate with each other via cytokines. Interleukin-27 (IL-27) is a heterodimeric cytokine formed by
non-covalent interactions of the subunits p28 and EBI3. IL-27 is induced by pattern recognition receptor (PRR)
activation in mononuclear phagocytes (AMs, monocytes, dendritic cells). IL-27 ligation with its unique receptor
chain, IL-27RA, on lymphocytes initiates STAT1/STAT3 phosphorylation. IL-27RA signaling initiates pleiotropic
programs, which can first intensify acute inflammation and later limit prolonged T cell activation. Our preliminary
data support the new concept that IL-27 is a critical player of the host response to Legionella infection. IL-27 is
elevated in broncho-alveolar lavage fluids of human patients with Legionnaires’ disease and IL-27RA deficient
mice are more resistant to infection. Here, we propose to test the central hypothesis that IL-27 is produced by
Legionella infected mononuclear phagocytes and initiates dichotomous programs in lymphocytes, that include
the protective activation of NK cells and adverse T cell-mediated immunosuppression in lungs. Aim 1) To pinpoint
the cellular source(s) of IL-27 during Legionellosis within the subsets of lung mononuclear phagocytes. We aim
to assess the contribution of relevant PRR immunosensors for IL-27 induction by L. pneumophila. Samples from
Legionnaires’ disease patients will be studied for associations of IL-27 with the PD-1/PD-L1 axis and soluble
markers of immunopathology. Aim 2) To characterize the functional consequences of constitutive IL-27RA
ablation in infected IL-27RA-/- mice, and to study the host response programs by single-cell, multi-dimensional
proteotranscriptomics (CITE-Seq/Total-Seq). We will also evaluate neutralizing IL-27 antibodies and an
engineered decoy receptor to improve pneumonia severity in mice. Aim 3) Based on preliminary data, we aim to
study the altered inflammatory response of our novel conditional mice with NK cell-specific deletion of IL-27RA.
We will investigate whether NK cell maturation is associated with a switch of IL-27RA controlled transcriptional
programs through engaging non-STAT phosphoprotein signaling. Aim 4) To investigate the roles of IL-27RA in
conventional and unconventional T cells with a mechanistic focus on co-inhibitory/co-stimulatory receptors during
lung infection with L. pneumophila and L. longbeachae in mice. In summary, the proposed studies will test the
novel concept that IL-27 plays a critical role for the lung host response and outcome of Legionellosis and that IL-
27RA initiates selective programs in NK cells versus T cells.

Public health relevance
Project Narrative Legionella are facultative, intracellular bacteria residing in aquatic environments from which contaminated inhaled aerosols cause accidental infections leading to an increasing incidence of Legionnaires’ disease in the United States. Here, we hypothesize a critical role of the immune-modulatory cytokine, IL-27, signaling via its IL-27RA receptor for the immune pathogenesis of Legionellosis. The proposed studies aim for new insights into the molecular pathways of IL-27 production in infected macrophages and the lymphocyte-type specific activities of IL27RA to establish a solid knowledge basis for targeted therapies in future.